Using Practice Facilitation and Operationalizing Referral Information Technology (UP FOR IT) to Increase DSMES Utilization

PROJECT SUMMARY
The prevalence of diabetes in Kentucky is ~25% higher than the national average, and rural areas within
Kentucky face an even higher burden of diabetes and its related complications. Diabetes self-management
education and support (DSMES) services are integral to quality diabetes care. Substantial evidence shows that
DSMES participation improves diabetes outcomes and is cost-effective. Despite strong evidence of benefit and
clear guidelines from the American Diabetes Association recommending its use, <10% of eligible individuals
complete DSMES. Determinants that contribute to low DSMES uptake exist at multiple levels and include
clinician awareness, geographic availability, cost and reimbursement, and referral mechanisms. Although the
Kentucky Department of Public Health administers a statewide DSMES program that is free to participants and
available face-to-face in 80/120 counties and by telehealth in all counties, DSMES utilization remains low
across Kentucky. In response to the current RFA seeking to test innovative and pragmatic approaches to
facilitate greater use of DSMES, we propose testing and evaluating a clinic-level intervention that implements
health information technology (automated patient identification and a bidirectional referral system) to reduce
barriers related to identification and referral of eligible patients and engages clinical teams in a practice
facilitation collaborative to increase clinician awareness and overcome clinic-level barriers. We will achieve this
through three aims: 1) Planning – implementation science-guided evaluation and adaptation of an existing pilot
diabetes clinical quality improvement program; 2) Implementation – of the adapted intervention; and 3)
Evaluation - of intervention components using the Practical, Robust Implementation and Sustainability Model
(PRISM). We will adapt the proposed intervention from a successful pilot project that used health information
technology and a collaborative quality improvement approach to increase DSMES utilization at participating
clinics by >100%. We will use a pragmatic cluster randomized study design to evaluate implementation
effectiveness and will use an implementation science framework to guide evaluation of the feasibility,
acceptability, and sustainability of the intervention. To achieve the study aims, we have partnered with the
Kentucky Department of Public Health (DSMES provider), the Kentucky Regional Extension Cooperative
(practice facilitation partner), Kentucky Health Information Exchange (health information technology partner)
and two healthcare systems in rural Kentucky. This pilot and feasibility study will provide insight on pragmatic,
scalable, and sustainable strategies to increase DSMES utilization. Findings will generate key preliminary data
that will guide planning of an R01-level dissemination and implementation trial with the goal of reducing
diabetes-related morbidity and mortality.

Public health relevance
PROJECT NARRATIVE Diabetes Self-Management Education and Support (DSMES) is an evidence-based, small group educational program that helps people with diabetes better control blood sugar (improved hemoglobin A1c) and reduce diabetes-related complications and healthcare costs. DSMES is strikingly underutilized with fewer than 10% of eligible patients receiving this helpful service due to patient-, clinician-, and health system-level barriers that include low clinician awareness and lack of integrated referral processes between clinics and community- based DSMES programs. Our project tests a clinic level-intervention that implements an electronic clinic- community referral system and creates a practice facilitation collaborative to empower clinical teams to identify and address DSMES barriers with the goal of increasing DSMES utilization.